2025 Myogenesis Gordon Research Conference and Gordon Research Seminar

Abstract
This proposal requests partial support for an international meeting on Myogenesis as part of the Gordon
Research Conference (GRC) and Gordon Research Seminar (GRS) series to be held at the Renaissance
Tuscany Il Ciocco Resort Lucca (Barga), Italy June 7-13 2025. The international meeting on Myogenesis has
historically been viewed as one of the preeminent skeletal muscle meetings, attracting speakers and attendees
from around the world. A major goal of the 2025 Conference is to identify mechanisms that contribute to both
healthy physiological function and, when dysregulated, muscle pathology during aging or disease. Leaders in
the field will present recent unpublished data to educate conference attendees while stimulating interactive
discussion amongst the group. Additional program events including poster sessions, scheduled social events,
local outings, organized mentoring and networking tables at mealtimes, and informal gatherings in the
afternoons will ensure maximal levels of interaction between established scientists and junior
scientists/trainees: this meeting has historically been rated by attendees as extremely informal and collegial
with excellent interactions between trainees and more senior researchers. Thus, we expect the 2025
Myogenesis GRC will provide an ideal scenario to stimulate new breakthroughs in muscle biology and to
benefit attendees at every professional level. In addition, four afternoon and evening poster sessions will
stimulate interactions between all attendees. We will also provide education, networking opportunities, and
career path mentoring to junior scientists through the GRS, a two-day conference program targeting graduate
students and postdocs that takes place immediately preceding the GRC. The GRS will conduct four sessions
of talks and two poster sessions by graduate students and postdocs. Moreover, during the GRC, 4 sessions of
"poster previews" will provide a forum for junior scientists to highlight their work and receive feedback from
other participants (approximately 50% of trainees attending will present in this forum). These activities
represent a unique opportunity for the next generation of scientists to present their research on myogenesis,
interact with their peers, and form new collaborations. Achieving these aims will place the field in a better
position to accelerate the advancement of muscle biology and thus the development of new avenues to
promote muscle health. The venue of the conference at Il Ciocco Italy offers a relaxing atmosphere conducive
to creative thinking and the exchange of ideas that will benefit attendees at every professional level. Thus, we
expect the 2025 Myogenesis Gordon Research Conference will provide both a stimulating program and an
ideal setting for attendees to advance their understanding of skeletal muscle biology.

Public health relevance
Project Narrative The 2025 Myogenesis Gordon Research Conference will bring together basic and applied muscle researchers from around the world to exchange information on the latest conceptual advances in skeletal muscle research. Topics to be covered include Regulation of Gene Expression in Muscle; Muscle Diseases and Therapies; The Muscle Stem Cell Niche; Physiological Regulation of Myogenesis; Development of Muscle and Associated Tissues; Muscle Diseases and Therapies; Aging in Health and Disease; and Innovations in Muscle Research. The health relatedness of this application comes from the focus on unpublished research to be shared by our speakers which will be used to advance our understanding of mechanisms regulating muscle health.